Intranasal LIF to improve neurological recovery from perinatal hypoxia-ischema

Our studies have established that there is an early regenerative response initiated by
the neural stem cells and progenitors (NSPs) in the subventricular zone (SVZ) in
response to a perinatal hypoxic-ischemic (H-I) insult and that the expansion of the NSPs
requires the cytokine leukemia inhibitor factor (LIF). We have collected new data that
reveals other functions of LIF as LIF haplodeficient animals sustain worse injury
compared to wild type mice. Complementing those loss of function studies, we provide
preliminary data to show that delayed intranasal LIF administration, reduces the extent
of cerebral neuronal loss, increases proliferation in the SVZ and improves neurological
function in a mouse model of near term hypoxia-ischemia. Therefore, the premise of
this proposal is that LIF is an essential neuroprotective and regenerative cytokine
and that the non-invasive, intranasal administration of LIF can promote
regeneration and decrease the long-term burden of neurological deficits. We will
test this premise by performing experiments using pre-term and near-term mouse
models of perinatal injury with the following 3 specific aims: 1) that LIF haplodeficient
mice will sustain greater neuronal and glial cell damage after a developmental brain
injury accompanied by worse neurological disabilities; 2) that delayed intranasal LIF
administration will stimulate the numbers of stem cells and progenitors to repair the
damaged gray and white matter and 3) that the extent of axonal regeneration and
function can be improved by delayed intranasal LIF administration. During the course of
our studies we will elucidate the mechanisms through which LIF is exerting its potent
neuroprotective and regenerative actions. As it is likely that many perinatal insults occur
during the antenatal period and go undetected, the knowledge obtained from these
studies could lead to therapeutics that could be administered to infants subacutely to
enable the damaged brain to develop normally from its endogenous stem cells, thus
decreasing the incidence and life long cognitive, motor and emotional handicaps that
occur as a result of developmental brain damage.

Public health relevance
Despite progress in reducing the extent of injury after perinatal hypoxic-ischemic brain injury, there are presently no approved therapeutics to both reduce the extent of secondary injury and promote regeneration. The goal of this proposal is to use a mouse model of perinatal hypoxic-ischemic brain injury to test the therapeutic efficacy of a cytokine that we hypothesize will both preserve injured neurons and stimulate the replacement of damaged neurons and glia from the resident neural stem cells of the subventricular and subgranular zones.